Assessing the role of SP140 in enhanced resistance to Cryptococcus neoformans

Project Abstract
The HIV/AIDS associated fungal pathogen Cryptococcus neoformans (Cn) is responsible for 20% of
global HIV-related mortality and has been designated on the World Health Organization Critical Fungal Patho-
gens list. Cn is the causative agent of cryptococcal meningitis (CM), a severe infection of the central nervous
system that causes irreversible neurological damage and death. Mortality rates from CM are >30% depending
upon global region. To reduce global mortality from CM, a greater understanding of host immune responses
and better in vivo models are needed to produce clinically translatable findings. Cn is found ubiquitously in the
environment and inhalation of Cn spores leads to infection of the alveoli and deep pulmonary tissue. In immu-
nocompetent individuals, Cn infection is contained within pulmonary granulomas leading to containment of Cn
cells. Granulomas are formed through signaling between the innate and adaptive immune responses, specifi-
cally between macrophages and CD4+ T cells. Advanced HIV coinfection causes depletion of CD4+ T cells
and disrupts the signaling needed to maintain granuloma structure. Granuloma breakdown leads to fungal es-
cape and disseminated CM disease. Better understanding of granuloma formation and breakdown can lead to
the development of therapeutics to prevent dissemination in immunocompromised individuals. However, cur-
rent in vivo models do not replicate human the necrotic Cn granulomas observed in humans. My preliminary
data identified C3HeB/FeJ mice as producing Cn granulomas that better recapitulate necrotic granulomas in
humans. In addition, these mice have better survival when infected with Cn compared to C57Bl/6 (B6) mice.
However, the mechanism and genes that drive this phenotype are unknown. Previous studies using Mycobac-
terium tuberculosis (Tb) showed that deficiencies in the immune regulating gene Sp140 is involved in the
C3HeB/FeJ necrotic granuloma response against Tb. Therefore, my central hypothesis is that sp140-deficieny
is responsible for the production of necrotic Cn granulomas and increased resistance against Cn. To test my
hypothesis I propose the following Aims: Aim 1) Determine the role of sp140-deficiency in the immune re-
sponse against Cn by measuring differences in survival, fungal burden, Cn blood antigen level, cytokine abun-
dances, and immune cell populations; Aim 2) Define the histological and transcriptional profiles of sp140-defi-
cient Cn granulomas over time using microscopy and spatial transcriptomics, and determine the mechanisms
by which CD4+ T cell depletion leads to granuloma breakdown. These findings will expand our understanding
of protective host immune responses against Cn, establish a method for modeling human-like Cn granulomas
in mice, and provide insight into the mechanism of granuloma degradation during advanced HIV coinfection.

Public health relevance
Project Narrative Global mortality among immunocompromised and HIV+ populations by Cryptococcus neoformans (Cn) remains high but development of novel immunomodulatory therapeutics is hampered by 1) poor understanding of the immune responses against Cn and 2) a lack of mouse models that recapitulate human Cn disease. The proposed research addresses this through development of a new Cn-infection mouse model that produces human-like lung granulomas and defining the immune response in these protective granulomas. We also mimic disease in advanced HIV patients to understand how immune deficiency causes granuloma breakdown leading to disease.